Vision Research Training Program

PROJECT SUMMARY/ABSTRACT

This proposal from the University of Michigan builds upon a long-standing tradition of training graduate students and postdoctoral fellows for careers in vision research. The centerpiece of our current training efforts is the Vision Research Training Program (VRTP), which is now in its 20th year. The goals of the VRTP are to provide breadth in research training and professional development to keep pace with the opportunities for careers in vision research. The VRTP will (1) recruit and support candidate-level predoctoral fellows as they undertake and complete their thesis research, (2) recruit and support postdoctoral fellows as they begin independent research careers, (3) provide a formal structured education, (4) and provide all trainees with a program of professional development specific to vision research.
Members of the Training Faculty are experienced mentors, who are well-funded, productive scientists that utilize the eye and visual system as models for basic and translational studies. The PI/PD is Dr. Patrice E. Fort, Associate Professor of Ophthalmology and Visual Sciences and, Associate Professor of Molecular and Integrative Physiology. The Associate Director is Dr. Sara Aton, Associate Professor of Molecular, Cellular and Developmental Biology of the College of Literature, Science, and the Arts.
The annual admission and enrollment of training grant-eligible doctoral students justify our request for 3 pre-doctoral positions per year. Similarly, the number of training grant eligible postdoctoral fellows currently in training justify our request for 1 postdoctoral position per year.
The University of Michigan is committed to create an outstanding academic environment for the successful training of all students and postdoctoral fellows. The University in general, and the VRTP more specifically, values the contributions of every faculty, student and staff member and their role to establish the best possible biomedical sciences workforce.
The University of Michigan requires the highest level of research integrity from its faculty, staff and students. All trainees participate in a multi-tiered program that teaches responsible conduct and emphasizes rigor and reproducibility in the administration of research.

Public health relevance
PROJECT NARRATIVE This proposal seeks support for a program at the University of Michigan to train graduate students and postdoctoral fellows in vision research. Research performed by doctoral students and postdoctoral fellows supported by this training grant directly addresses problems in basic and translational science with important implications for understanding normal biological processes that impact human vision and diseases that result in vision loss. Training students and postdoctoral fellows adds to the workforce of outstanding vision scientists in academic and applied research and advances our knowledge in areas that are important for improving human health.